Bacterial Cell Surfaces Gordon Research Conference and Seminar

PROJECT SUMMARY
This proposal seeks support for the 25th Gordon Research Conference (GRC) on Bacterial Cell Surfaces, which
will be held on June 23-28, 2024, at Mount Snow Resort (West Dover, VT) and will have an associated Gordon
Research Seminar (GRS). The GRS, which is organized by and for graduate students and postdocs, will be on
June 22-23, 2024, at Mount Snow. The GRC on Bacterial Cell Surfaces is unique among envelope-related
conferences because it connects cutting-edge research on bacterial envelope biology to the medically important
downstream consequences of the bacterial surface including infectious diseases, antibiotic resistance, and
microbiome-host interactions. The conference will feature the latest, largely unpublished, and most impactful
research highlighting how the bacterial surface influences and can be targeted to promote human health. It will
include a diversity of topics, model systems, and approaches combining biochemistry, genetics, structural
biology, cell biology, biophysics, imaging, and modeling. The oral program will contain 9 sessions: (1) Envelope
Macromolecular Machines; (2) Cell Division and Morphogenesis; (3) Sensing through the Cell Envelope; (4)
Coordinating and Balancing Cell Envelope Biogenesis; (5) Modification and Evolution of the Bacterial Envelope;
(6) Maintenance of the Cell Envelope; (7) Targeting the Cell Envelope with Antimicrobials; (8) Interplay between
the Bacterial Envelope and Communities; and (9) Envelope-dependent Behaviors. These topics will provide a
platform for the development of antibacterial strategies, vaccine development, and studies of host-microbe
interactions. They are of great interest to researchers conducting basic and translational research and to the
mission of the NIH. In addition, the conference will include 4 poster sessions. We have selected a group of
leading expert scientists, including several rising junior researchers, as speakers and discussion leaders. This
group was selected by considering expertise and demographics. To provide a collegial atmosphere and foment
interactions between junior and established scientists and inclusivity, we will also feature many short talks from
junior scientists, facilitate roundtable discussions for junior scientists to engage with leaders of academia and
pharmaceutical industries, and host a GRC Power Hour to examine issues of inclusion and diversity. To integrate
the GRS and GRC, the GRS co-chairs will present a summary of their meeting at the GRC opening session and
two of the short talks featured in the GRC will be selected by GRS participants through voting. Furthermore, the
format of GRC meetings, with programmed discussion sessions and opportunities for informal gatherings in the
afternoons and evenings, conveys a collegial atmosphere that facilitates interactions between attendees of all
career stages and promotes networking and future collaborations. By bringing together researchers investigating
both basic science and its downstream impact on human health, this GRC will facilitate the generation of the
knowledge, new ideas and approaches, and interactions that are essential to fight infectious diseases and
antimicrobial resistance, and to understand the interdependence of host and its microbiota.

Public health relevance
PROJECT NARRATIVE The Gordon Research Conference on Bacterial Cell Surfaces and accompanying Gordon Research Seminar will bring together junior researchers, leaders of the bacterial envelope field, and members of the pharmaceutical industry to discuss cutting-edge research and the most-pressing questions about the bacterial cell surface and its impact on human health and disease. The conference will focus on disseminating the latest research on how the bacterial cell surface is built, adapts, evolves, and interacts with the outside world, as well as on the development of much-needed novel antibacterial strategies that target the cell envelope of disease-causing bacteria.